Penn - Center for AIDS Research - Inter-CFAR Meeting: Social and Behavioral Sciences Research Network

Abstract
This CFAR meeting supplement application requests funding to support the 2025 meeting of the Social and
Behavioral Sciences Research Network: SBSRN 2025. The meeting will be co-hosted by the Penn and UNC
CFARs and will partner with the Inter-CFAR Substance Use Research Committee and the National CFAR CAB
Coalition. SBSRN 2025 will target early stage investigators (ESI) whose work integrates social and behavioral
sciences in HIV prevention and treatment research. The meeting will be held in person to maximize opportunities
for networking with peers from other CFARs and ARCs, established investigators, and importantly, NIH program
officials. We have selected a venue in North Bethesda to increase opportunities for NIH staff to participate in
both the Mentoring Day and the Scientific Symposium. The overarching goal of the meeting is to engage and
energize early stage investigators working in HIV from CFARs and ARCs around the country by providing: 1)
updates and insights into the NIH research priorities and application and review processes; 2) opportunities to
present and receive feedback on emerging research concepts and applications being developed by participating
ESI; 3) meaningful interactions with NIH program officers, senior HIV investigators, and community leaders; and,
4) presentations on cutting edge science able to inform the HIV research agenda moving forward. Beginning in
2006, the SBSRN met annually through 2018 and again in 2022. Over this time, attendance averaged between
100 and 150 participants, and the meeting consistently received very positive evaluations, particularly among
the 259 ESI who participated as mentees. The SBSRN meeting has become a highly valued, shared resource
for CFARs around the country. It is uniquely focused on promoting transdisciplinary HIV research among
behavioral scientists from a variety of disciplines and places a high priority on personal interactions among
behavioral, clinical, and basic science investigators, NIH program officials, and ESI, particularly those from
under-represented racial and ethnic groups. The provisional theme of the proposed meeting is “The Role of
Behavioral and Social Scientists in Getting to Zero.” Funds will be used to cover the cost of the meeting venue
and travel for ESI and selected speakers.

Public health relevance
The 2025 meeting of the SBSRN will be co-hosted by the Penn and UNC CFARs and will partner with the Inter-CFAR Substance Use Research Committee (I-SURC) and the National CFAR CAB Coalition (N3C). The meeting will bring together early-stage investigators, established investigators from CFARs and ARCs, community representatives, and NIH program officials, will be fully aligned with the OAR and EHE research priorities, and will disseminate and critique cutting edge HIV science. SBSRN 2025 will begin with a day devoted to mentoring ESIs followed by a one-day scientific symposium and will provide attendees with opportunities for networking and collaboration development.